Mechanisms underlying sex differences in stress-induced alcohol seeking

Project Summary/Abstract
Historically, alcohol abuse and alcohol use disorders (AUDs) have been more common in men than women.
However, recent epidemiological data in younger cohorts of women suggest that this gender gap is closing.
Rates of risky/binge drinking in women are going up at a much faster rate than in men, women show a faster
transition from social use to dependence, and women suffer greater alcohol-related health problems. Thus,
identifying sex-specific neurobiological factors that underlie the development of problem drinking could lead to
improved treatment approaches. In particular, women have been shown to have increased craving in response
to alcohol-related cues and stressors relative to men, and neuroimaging studies show that this effect is
associated with differential activation of brain circuits including the amygdala. We have found that female rats
also show a greater relapse-like response to alcohol-associated cues, particularly when combined with an
acute stressor, similar to the human studies. Moreover, we also have evidence for increased glutamatergic
signaling in the basolateral amygdala (BLA) of female rats, raising the possibility that alcohol-associated
memories may be more readily encoded in the BLA of females relative to males, and/or that the neurons
encoding alcohol memories are more responsive to acute stress and able to drive activity in circuits controlling
craving and relapse. Importantly, we have previously shown that differences in circulating gonadal hormones
do not mediate the sex difference in behavior, suggesting that fundamental differences at the synaptic or circuit
level underlie differential relapse-like behavior. For example, we have found that glutamatergic synapses from
sensory thalamus to the BLA are critical for the encoding and extinction of cocaine-associated memories, and
that depotentiating these synapses is sufficient to reduce cocaine relapse-like behavior. However, no one has
previously investigated whether alcohol-cue memories are similarly encoded or if there are differences
between males and females in the neural mechanisms mediating alcohol memory formation. Thus, in Aim 1 we
will compare plasticity related mechanisms in the BLA regulating alcohol memory formation and extinction in
males and females. In Aim 2, we will use genetically-encoded calcium indicators and miniature
microendoscopes to image neural activity (calcium signals) in males and females when alcohol-cues are
presented in the presence or absence of acute stressors. Finally, in Aim 3 we will use comprehensive cFos
mapping to determine if males and females engage similar or different circuits during stress+/-alcohol-cue-
induced relapse-like behavior. These results will inform if sex differences are due to altered circuit engagement
that would point to sex specific neural targets for treatment. All together, these studies will provide a
comprehensive analysis of how alcohol-cue memories are formed, modulated by stress, what other circuits are
engaged, and if there are sex differences in any of these neurobiological factors that could explain the
increasing vulnerability of females to alcohol-related disorders.

Public health relevance
Project Narrative The present project aims to determine if there are sex differences in the neurobiological mechanisms underlying the formation of alcohol-associated memories or their modulation by acute stressors that mediate increased vulnerability to relapse in females. We will use a rodent model to determine if there are sex differences in 1) the amygdala-dependent plasticity that underlies alcohol-related learning, 2) the modulation of alcohol-associated neural ensembles by stress, or 3) the circuits activated by alcohol cues and stress, in order to identify potential targets for sex-specific treatment development.